Control of Type I Interferon Production in Response to Candida

PROJECT SUMMARY
Invasive bloodstream infection by the fungal pathogen Candida spp. remains one of the most common infections in
hospitalized patients, carrying a mortality rate of over 50%. Despite the current antifungal arsenal, these mortality rates have
not decreased, especially with the emergence of multi-drug resistant strains of Candida. Human SNPs implicate the type I
interferon (IFN) pathway with increased susceptibility to candidemia. Interestingly, mice deficient in components of the
type I IFN cGAS-STING pathway were more resistant to bloodstream Candida albicans infection. We recently established
that DNA contained in C. albicans extracellular vesicles (EVs) potently activates the cGAS-STING pathway as evidenced
by increased IFN stimulated genes, viperin production, IFN-β secretion, and phosphorylation of key downstream proteins
(i.e., TBK1 and IRF3). The mechanism and functional consequences of how this pathway contributes to the host response
to Candida infection remain unknown. Our findings regarding EVs were not exclusive to C. albicans but also expanded to
other fungi (e.g., Candida auris). We revealed that STING activation occurs independently of TLR9 and Dectin-1 signaling.
Additionally, knockdown or blockage of the cGAS functional site for TREX1, a key exonuclease that regulates the cGAS-
STING pathway, elevated viperin expression in EV-stimulated macrophages. These data form the groundwork to explore
further the consequences of type I IFN response in Candida infections and the basis of our long-term goal.
Our overall testable hypothesis is that the magnitude of STING-IFN signaling pathway activation determines the outcome
of invasive candidiasis as determined by fungal burden and survival.
To address this hypothesis, we propose the following three specific aims: [1] investigate the role of viperin and TREX1 in
the innate immune response to invasive candidiasis; [2] determine the impact of impairment of EV production by C. albicans
on the pathogenicity of invasive candidiasis; and [3] exploit the STING pathway to induce protection against invasive
candidiasis. Successful completion of the proposed studies will provide a greater understanding of type I IFN response to
invasive candidiasis and may lead to novel therapeutic targets to modulate the immune response to improve clinical
outcomes in patients with candidemia.

Public health relevance
PROJECT NARRATIVE Invasive fungal infections are some of the most dreaded infections for immunocompromised patients. This application seeks to understand how type I interferons, important molecules in the innate immune system, control the outcome of fungal infections.